Vascular Smooth Muscle Vps34 in Pulmonary Arterial Hypertension

PROJECT SUMMARY/ABSTRACT
Pulmonary arterial hypertension (PAH) is a progressive and rapidly fatal disease with no cure. PAH manifests
by remodeling of small pulmonary arteries, leading to increased PA pressure, elevated right ventricular (RV)
afterload, heart failure, and death. One of the key components of PA remodeling is increased proliferation and
survival of PA vascular smooth muscle cells (PAVSMC). Recently, I found that activation of Class III
Phosphatidylinositol 3-kinase vacuolar protein sorting 34 (Vps34), evidenced by lack of inhibitory
phosphorylation at Ser164 (P-S164-Vps34), promotes hyper-proliferation of PAH PAVSMC, which is Akt-
dependent and is associated with accumulation of Vps15, deficiency of TSC2, activation of mammalian target of
rapamycin complex 1 (mTORC1), increased growth and proliferation of PAVSMC, and pulmonary vascular
remodeling in PAH. Similar to human PAH, decreased P-S164-Vps34 was also observed in PA VSM from
experimental rodent PH models, which is reversely correlated with increased PA medial thickness, and was
associated with increased RV systolic pressure (RVSP) and RV hypertrophy. Further, I show that Vps34
inhibition by siRNA significantly decreased PAH PAVSMC proliferation and survival, reduced Vps15 and restored
TSC2 protein levels, and inactivated mTORC1. Additionally, our data show that pharmacological inhibition of
Vps34 reverses PAH-specific signaling abnormalities, selectively inhibits proliferation and promotes apoptosis
in human PAH PAVSMC, and significantly attenuated established pulmonary vascular remodeling and reduced
RV hypertrophy in mice with SU5416/hypoxia-induced PH. Based on our preliminary data, I hypothesize that
Vps34 is activated in PAH PAVSMC in an Akt-dependent manner, leading to increased PAVSMC proliferation
and survival, pulmonary vascular remodeling, and PH via modulating Vps15 and TSC2-mTORC1 axis. I also
propose that pharmacological inhibition of Vps34 inhibits proliferation and induces apoptosis in PAH PAVSMC,
and attenuates or reverses pulmonary vascular remodeling and PH. I will test my hypothesis using three specific
aims: Aim 1 will examine the status and mechanisms of Vps34 regulation in PAH pulmonary vasculature, Aim 2
will determine the role of Vps34 in human PAVSMC proliferation and survival, and Aim 3 will evaluate whether
molecular or pharmacological inhibition of Vps34 attenuates or reverses experimental PH in vivo. The proposed
study will identify a new critical mechanism of pulmonary vascular remodeling and dissect a new remodeling-
focused molecular target for therapeutic intervention.

Public health relevance
PROJECT NARRATIVE The proposed research is highly relevant to public health because pulmonary arterial hypertension (PAH) is a progressive vascular disease with high morbidity and mortality. The proposed studies will define the role of vacuolar protein sorting (Vps34) in regulating increased proliferation and survival of pulmonary vascular smooth muscle cells in PAH; will provide insights into the molecular mechanisms that are important in the pathogenesis of PAH; and will explore whether Vps34 could serve as a target pathway for pulmonary vascular remodeling- focused therapeutic interventions.